Poly(ADP-ribose)-dependent TDP-43 pathology in oxidative stress (R21)

Abstract
Frontotemporal dementia (FTD) is an Alzheimer-related dementia disease (ADRD) and involves nuclear
egress and cytoplasmic Transactivation response DNA binding protein 43 (TDP-43). The mechanisms for
pathological export of TDP-43 or its accumulation in the cytoplasm is not clearly defined. Although, studies
on disease-causing mutations have revealed that defects in nuclear import may be in part responsible for
TDP-43 accumulation in the cytosol as these mutations change the properties of the protein. However, it
remains largely unclear how TDP-43 accumulates in the cytosol, as the majority of the TDP-43 dependent
pathologies are sporadic. TDP-43 contains two RNA recognition motifs (RRMs), a nuclear export signal
(NES), and a nuclear localization signal (NLS) in its N-terminus, and binds poly (ADP-ribose) polymer (PAR)
via a PAR-binding motif embedded in its NLS. Studies have shown that PAR inhibitors can inhibit TDP-43
pathology, and binding of PAR to TDP-43 can change its biophysical characteristics in solution. Exportin 1
(XPO1) mediates the NES-dependent export of proteins from the nucleus. TDP-43 is a 43kDa protein that
may not require XPO1-dependent export under basal conditions but our data indicates that under neuronal
stress conditions TDP-43 egresses the nucleus via XPO-1 dependent export. We hypothesize that in disease
conditions like FTD type ADRD and related diseases; PAR binds TDP-43 in the nucleus and facilitates its
interaction with XPO-1, which subsequently enhances the egress of TDP-43 from the nucleus to cytosol.
This proposal is supported our preliminary data that both PARP inhibitor BMN673 and XPO-1 inhibitor KPT-
185 inhibit the cytosolic accumulation of TDP-43 in neurons and TDP-43 and XPO1 interact following PARP
activation. In this proposal, we plan to study the alterations in TDP-43 in mouse cortical neurons exposed to
oxidative stress. Oxidative stress is a common pathological process mediating protein mislocalization,
aggregation, and cell death in virtually all neurological disorders including FTD. Oxidative stress via H2O2 in
cortical neurons mediates a robust TDP-43 cytosolic localization. Therefore, it is likely that pathophysiological
mechanisms identified in the oxidative stress model in cortical neurons can closely overlap/mimic pathological
mechanisms in FTD and other ADRD involving changes/mislocalization of TDP-43.
We will use biochemical, cell biological and imaging techniques in combination with proximity ligation assays,
CryoEM, and Hydrogen/Deuterium Exchange mass spectrometry to assess the PAR-dependent alteration in
TDP-43 and its interaction with XPO-1 that leads to an increase in the release of TDP-43 from the nucleus
and subsequent accumulation/aggregation in the cytoplasm. These studies will help in understanding the
pathophysiological mechanisms of TDP-43 accumulation in FTD, ALS, and other ADRD/dementia related
diseases involving TDP-43

Public health relevance
TDP-43 is a nuclear protein that translocates to cytosol in FTD, AD related dementia diseases (ADRD), and ALS. This proposal will investigate how PAR facilitates TDP-43 and XPO-1 interaction and accelerates the egress of TDP-43 from the nucleus. These studies may be useful in understanding the pathological alteration in TDP-43 dynamics in FTD, ADRD, and ALS.